GCDH Addiction in Melanoma

Project Summary
In this revised R01 application we propose to characterize a novel mechanism underlying the control of apoptosis
by the mitochondrial enzyme GCDH, and to extend the development of small molecule GCDH inhibitors to treat
melanoma. In our preliminary results we discovered that addiction to GCDH activity is critical for cell survival in
melanoma, but not liver, breast or prostate tumor cells, a discovery that was confirmed in patient specimens
where inverse correlation between GCDH expression and survival is seen in melanoma. Our studies reveal
induction of apoptosis in melanoma cell lines following GCDH inhibition, a phenotype dependent on the upstream
DHTKD1 enzyme. Key in mediating GCDH activities in melanoma is NRF2, which is subjected to glutarylation
upon inhibition of GCDH. NRF2 glutarylation promotes its stability and transactivation of an apoptotic UPR
signaling consisting of ATF4, ATF3, CHOP and CHAC1, the latter being components of the Unfolded Protein
Response (UPR). Inhibition of GCDH effectively induces apoptotic UPR signaling in melanoma but not in liver
or breast cancer cells, substantiating the selectivity of the pathway as mapped in cell lines and patient tumor
samples. These observations provide the foundation for our hypothesis that GCDH-mediated regulation
of NRF2-UPR signaling constitutes a novel pathway controlling melanoma cell survival. Our studies will
(i) map the NRF2 glutarylation pathway in melanoma, generate antibodies specific to glutarylated NRF2, monitor
NRF2 glutarylation in specimens from melanoma patients both responsive and non-responsive to therapy (ii)
assess how GCDH impacts tumor development, progression and response to targeted and immuno therapy in
genetic mouse models. YUMM1.7, MaRas, B16F10 lines will be modified to express inducible KD of GCDH
before their inoculation into syngeneic WT or GCDH KO mouse models which will be monitored prior and
following therapy (iii) advance development GCDH inhibitors as novel therapeutic modalities. SBI-0690564 was
confirmed in vitro and in cultured melanoma cells, where it phenocopies genetic inactivation of GCDH and inhibits
melanoma tumors in mice. We will characterize and further develop a novel class of inhibitors to target GCDH
and determine their effectiveness in culture and in vivo using mouse models. Our studies will establish novel
paradigm for GCDH signaling as we define mechanisms underlying GCDH control melanoma tumor fate.
Understanding the addiction to GCDH in melanoma provides the foundation for the development and evaluation
of novel GCDH inhibitors to selectively target these and possibly other select cancers.

Public health relevance
Project Narrative This revised application focuses on the discovery that melanoma are selectively addicted to the lysine catabolism enzyme GCDH, which controls NRF2 glutarylation, impacting transactivation of apoptotic UPR signaling in melanoma. The newly discovered GCDH-NRF2-UPR axes constitutes a novel paradigm for control of melanoma survival and offers novel therapeutic targets.